BLRD Research Career Scientist Award Application

The mission of my Neuroimmunology Research Program is to develop a deep biological understanding of
autoimmune, demyelinating and neurodegenerative processes that affect the central nervous system (CNS) and
certain types of cancer and to identify and test novel disease-relevant therapies that can be brought to market
to treat and/or cure these conditions. Veterans are currently developing intractable chronic neurological diseases
such as multiple sclerosis (MS) and stroke, service related injuries including traumatic brain injury (TBI) and
post-traumatic stress disorder (PTSD), substance abuse of methamphetamine and alcohol and cancer. Studies
carried out by our laboratory are highly relevant to these devastating conditions due to our development of a
novel therapy, DRhQ, that targets a common underlying mechanism, the MIF/CD74 axis that promotes chronic
inflammation in the CNS and tumor growth in cancers. The result of MIF/CD74 signaling is peptide-specific T-
effector cell activation and recruitment of inflammatory cells from blood into the CNS. Our main interest has
been multiple sclerosis, a paralytic disease that affects ~1 million Americans. We recently discovered that MS
males with high-expression MIF gene polymorphisms have an increased risk of developing progressive MS that
results in severe loss of brain and motor functions (PNAS 2017). To date there are few if any treatments that
can prevent conversion from relapsing to progressive MS. This unmet need stimulated our design of a third-
generation VA and OHSU patent-protected CD74 ligand called DRhQ, now licensed by VA/OHSU to Artielle
ImmunoTherapeutics Inc. DRhQ has increased affinity for CD74 and is thus a more potent inhibitor of MIF-1
and MIF-2 binding than our previous constructs. Moreover, DRhQ treatment of chronic EAE reversed
demyelination in corpus collosum and optic nerves, making it an ideal candidate drug for blocking transition from
relapsing to progressive MS. This discovery now supports a precision medicine approach for treatment of
patients who are high MIF expressers. We currently are pursuing commercialization of DRhQ through Phase 1,
2 and 3 clinical trials. Our recent investigations identified key excipients to maintain >95% monomeric DRhQ as
required by FDA for clinical testing. Our current strategy is to manufacture monomeric DRhQ suitable for human
studies and carry out a first-in-human, FDA-approved Phase 1 study in healthy individuals to establish safety,
tolerability and biomarker activities of the DRhQ drug substance (hopefully starting in 2025). Currently we are
working with Virogenomics BioDevelopment, Inc. and the Gates Biomanufacturing Facility, Denver, CO for the
manufacturing and purification steps. Assuming positive Phase 1 results, we then plan to carry out Phase 2 and
Phase 3 trials using DRhQ to treat MS, stroke, TBI, methamphetamine use disorder and cancer in NIH and VA
multicenter studies. These proposed clinical trials leading to commercialization of DRhQ could have a formidable
impact on many human diseases, including those targeted by VA Research as essential for Veterans’ health.

Public health relevance
Studies carried out by our laboratory are highly relevant to the treatment of acute and chronic degenerative conditions of the central nervous system (CNS) and cancers that often afflict Veterans. We have developed of a novel therapeutic construct, DRhQ, that targets and competitively inhibits a common underlying mechanism, the MIF/CD74 axis that promotes inflammation in the CNS as well as tumor growth. Our work has demonstrated that DRhQ could potentially be used to treat Veterans with progressive multiple sclerosis as well as other devastating CNS afflictions including stroke, traumatic brain injury and methamphetamine induced cognitive disability, as well as melanoma and triple-negative breast cancer. The current focus of our VA Research Program is translational, with the goal of bringing our VA/OHSU patented drug, DRhQ to market, thus addressing a critical unmet need for the VA.